Elucidating the molecular determinants of Henipavirus envelope-antibody and envelope-receptor interactions on viral entry

PROJECT SUMMARY:
The identification of new Henipaviruses (HNVs) in Africa, China and Australia lend way to concerns about the
risk of possible spillover events. Yet, there are no FDA approved therapeutics and the role of receptor usage on
pathogenicity is still undetermined. Within this proposal, we aim to leverage our extensive preliminary results
to further our understanding of the molecular determinants of envelope-antibody and envelope-receptor
interactions on viral neutralization and viral pathogenicity. In recent work, we have identified an immune-
accessible region on the NiV and HeV fusion glycoprotein that is targeted by several antibodies. Experiments
proposed in Aim 1 will elucidate a mechanism for how these antibodies neutralize HNVs and will characterize
novel antibodies against the divergent GhV fusion glycoprotein by utilizing a rapid, directed-evolution platform
to identify escape mutants. Additionally, we have performed structure-guided mutagenesis to better
understand HNV receptor binding protein and receptor interactions. The experiments directly proposed in Aim
2 will further characterize these mutants and assess the ability to confer use of this receptor to other HNVs using
viruses. The work proposed here will ultimately support the development of HNV therapeutics and the
understanding of the contributions of receptor usage on HNV pathogenicity.

Public health relevance
PROJECT NARRATIVE: Henipaviruses are lethal, paramyxoviruses that have been recognized by the World Health Organization as a top, emerging disease likely to cause major epidemics because of the yearly outbreaks in Bangladesh/India and evidence possible spillover events into human populations in Africa. Despite this risk, we still do not fully understand all the factors that contribute to viral pathogenicity. The studies proposed in this application will characterize novel, neutralizing antibodies against divergent Henipaviruses and will generate useful resources to further our understanding of the role receptor usage plays in viral pathogenicity.